Identifying Multimodal Predictors of Response to Parent-Based Treatment for Pediatric Anxiety

Anxiety disorders are the most prevalent childhood psychiatric disorders, impacting up to one third of youth.
Pediatric anxiety disorders are highly impairing and, when not effectively addressed in childhood, persist
across the lifespan and predict the onset of additional psychiatric disorders. Up to 50% of youth who receive
the current first-line psychosocial treatment for pediatric anxiety do not sufficiently improve, highlighting the
urgent need to improve treatment response rates. Prior research underscores the critical role of parents in
supporting children’s fear regulation. Across species, parental presence is associated with alterations in key
corticolimbic circuitry associated with fear regulation. In healthy youth, parental modulation of corticolimbic
circuitry is in turn linked with reductions in anxiety. However, youth with anxiety disorders may be at risk for
becoming overly reliant on parents for fear reduction. The vast majority of anxious youth (90%) report relying
on their parent to help regulate their anxiety, and 97% of parents of youth with anxious children report
accommodating their child’s anxiety by engaging in behaviors to reduce their child’s distress. Although
accommodation reduces children’s anxiety in the short-term, it contributes to the maintenance and worsening
of anxiety in the long-term. Supportive Parenting for Anxious Childhood Emotions (SPACE) offers an entirely
parent-based alternative to traditional child-focused treatment that directly addresses parental accommodation
of anxiety and targets parental modulation of their child’s medial prefrontal cortex activation to fearful stimuli.
While SPACE has established efficacy, it is unlikely to be equally effective for all families, and questions remain
regarding which families are likely to benefit most from this targeted intervention. The current multimodal study
aims to identify specific pre-treatment predictors of the efficacy of SPACE as a step towards personalized
treatment for pediatric anxiety disorders. A well-characterized sample of children with anxiety disorders (n=212,
ages 6-12 years) completed an fMRI paradigm assessing youth’s neural reactivity to fearful face stimuli in the
presence versus absence of a parent. A subset of families was then randomized to complete 12 sessions of
SPACE (n=106) as part of an ongoing R61/R33-funded trial. Aim 1 will use a whole-brain approach to identify
neural mechanisms related to parental accommodation of youth’s anxiety pre-treatment. Aim 2 will examine
how pre-treatment individual differences in these neural and behavioral factors relate to changes in anxiety
symptoms following SPACE. Finally, Aim 3 will use connectome-based predictive modeling to predict the
efficacy of SPACE based on pre-treatment patterns of task-based functional connectivity. This study has
important implications for improving our mechanistic and clinical understanding of family-level factors involved
in anxiety. The results of this study could ultimately improve our ability to determine which families would
benefit most from SPACE and thus mark an important step towards personalizing treatment for pediatric
anxiety disorders.

Public health relevance
There is a pressing need to improve treatment response rates for pediatric anxiety disorders: pediatric anxiety disorders are highly prevalent and impairing, but up to 50% of youth who receive the current first-line psychosocial treatment for pediatric anxiety do not sufficiently improve. The proposed study will use data from an ongoing R61/R33 clinical trial to identify and characterize specific neural and behavioral predictors of the efficacy of a parent-based treatment for anxiety disorders. Findings from this study will elucidate the interplay between neural and behavioral family-level factors and examine how individual differences across modalities predict which families would benefit most from a targeted parent-based intervention, thus furthering efforts to improve treatment response rates by personalizing treatment for pediatric anxiety disorders.